Transforming Research And Clinical Knowledge in Geriatric Traumatic Brain Injury (TRACK-GERI)

PROJECT SUMMARY/ABSTRACT
This proposed project is within the scope of the parent award. No changes to project summary/abstract of
parent award.

Public health relevance
PROJECT NARRATIVE This proposed project is within the scope of the parent award. Thus, there are no changes to the project narrative of the parent award other than what is described in the Research and Career Plan which provides additional detail about assessments and analyses that will be performed by Allison Agnone within the scope of the original parent award Project Narrative.